Mitogenic and Oncogenic Regulation of ERK/RSK Signaling

Cancer is the 2nd leading cause of death in the US. The advent of new treatments such as immunotherapy and
targeted therapies have revolutionized the fight against cancer, and when combined with surgery, often result in
significant positive therapeutic responses. Unfortunately, some tumor cells gain the ability to resist drug- and
immune- therapies, which is often linked to their ability to metastasize. Indeed, metastasis ultimately underlies
the majority of patient mortality by cancer. A major unmet need in oncology is the prediction and prevention of
metastatic progression. Thus, understanding how tumor cells acquire metastatic potential and develop drug
resistance is critical to identifying novel therapeutic options and improving patient outcomes. It is of critical
importance to define the signaling mechanisms that contribute to altered growth, metabolism, motility and
survival associated with metastasis. Our long-standing goal is to uncover the molecular consequences of
Ras/ERK-MAP kinase signaling using biochemical, cell biological and genetic approaches in vitro and in vivo.
We have provided the foundational studies revealing how subtle differences in ERK signal strength, location and
duration are critical determinants of cellular outcomes. More recently, we demonstrated that different ERK
isoforms promote different cell fates. Specifically, we found that different docking domains within ERK2, the CD
domain and the DEF binding pocket (DBP), regulate different cellular outcomes, with ERK2 playing a major role
in promoting the epithelial-to-mesenchymal transition (EMT) through DBP signaling. Additionally, this EMT-like
phenotype was associated with increased motility, survival and metastasis in vivo and in vitro. Understanding
these mechanisms are part of the long-term goal of our basic research efforts to discover new potential targets
and identify new biomarkers, and to help resolve this currently unmet clinical need of targeting the metastatic
process. Thus, this grant application proposes to mechanistically investigate underexplored areas associated
with EMT and metastatic progression, taking advantage of discoveries made during the previous 30+ years
investigating the ERK pathway in my laboratory. Our goals include an investigation into: (i) the regulation and
role of H3.3 histone chaperones and H3.3 modifications, (ii) the role SP1/EGR1-downregulated genes and their
characterization as new metastasis suppressors, such as CHAF1b and MCEE; (iii) the function of massive
reorganization of endomembrane trafficking, lysosome and autophagosome function and the unexplored
regulation and function of various plasma and lysosome membrane transporters in the maintenance of cancer
stem cell properties, invasion, survival and chemoresistance during cancer progression and metastasis. In
conclusion, there is an essential need for greater understanding of the mechanisms associated with metastatic
behavior. Our expectations are that successful completion of the proposed work will impact cancer therapies
through identification of new biomarkers and novel drug targets that will yield small molecules that target the
invasiveness and survival of aggressive cancers.

Public health relevance
We have generated a vast amount of transcriptomic, metabolomic and proteomic data from a nine-day time course aimed at temporally defining the changing signaling and metabolic landscape contributing to the initiation and progression of molecular events promoting the epithelial to mesenchymal transition (EMT) in breast, lung and other cancers. These data have revealed several new links to EMT and metastasis, and we are currently focused on defining; (i) how ERK2 regulates chromatin remodeling and contributes to the initial phases of EMT via regulation of the HIRA complex and H3.3, (ii) how ERK2 signaling controls genetic and metabolic reprogramming to promote EMT-like features and metastatic progression via the SP1/EGR1-dependent down- regulation of genes suppressing metastatic behaviors and (iii) how ERK2 regulates extensive changes in membrane trafficking and lysosome biology for nutrient acquisition and survival and how differential expression of plasma membrane and lysosome membrane transporters during EMT, are regulated and contribute to cancer progression and invasion. These goals place us in the unique position to uncover and understand at a biochemical and molecular level new regulatory processes, new biomarkers and new potential targets for drug discovery, that are needed for personalized therapeutic intervention in many diseases, such as aggressive, metastatic cancers, a major unmet clinical need.